Influence of visual input on neuronal signaling in myopia

Myopia, or nearsightedness, is increasing at an alarming rate and reaching epidemic levels worldwide. Despite
optical correction, myopia increases the risk of developing blinding diseases so there is a critical need to
understand the underlying pathways that regulate its progression for effective prevention. Spending time indoors
is associated with more myopia progression whereas spending time in bright, outdoor environments is protective.
However, an effective explanation is still lacking for how these environments directly influence myopigenesis
because different environments are comprised of many visual cues, all of which have associations with myopia.
Importantly, all visual scenes are composed of bright and dark features and the visual system encodes these
features using the ON and OFF retinal pathways, respectively, through which all visual information is processed.
Broad disruption of ON pathways can influence myopia development but accumulating evidence suggests that
OFF pathways, or the signaling balance between the two pathways, may also be important. Additionally, ambient
light level is strongly associated with myopia progression and modulates ON and OFF visual signaling differently.
Currently, it is unknown how ON and OFF pathway signaling is affected in myopic eyes or the role of ON/OFF
signaling balance in myopia susceptibility across light levels. This proposal will address these gaps in knowledge
to increase our understanding of the visual pathways that regulate myopia development. Preliminary data
suggests that experimentally-induced myopia or exposure to myopigenic stimuli affects ON and OFF pathways
very differently, potentially altering ON/OFF retinal balance. Therefore, the hypothesis that disrupted ON/OFF
signaling balance initiates and drives myopia development will be tested. First, single-cell electrophysiological
recordings from ON and OFF pathways will be performed in isolated retinas and compared between myopic and
non-myopic eyes to determine which pathways are most impacted. Second, ON and OFF retinal pathway
balance will be disrupted in different lighting conditions while monitoring myopia susceptibility. In Aim 1,
quantification of ON and OFF signals from inner retinal neurons will be obtained in dim and bright ambient light
conditions. In Aim 2, quantification of ON and OFF ganglion cell receptive field signals will be obtained to
determine the extent of myopic changes in retinal output neurons. In Aim 3, ON/OFF retinal balance will be
disrupted in multiple lighting conditions with exposure to ON or OFF visual stimuli or pharmacological agents.
Myopia susceptibility and ocular biometry will be monitored throughout the disruption. The expected outcomes
of this proposal will provide powerful insight into what visual pathways are implicated in myopia progression and
may help inform which visual environments are optimal to preserve retinal signaling balance for myopia
interventions. This proposal aligns with the mission statement of the National Eye Institute by investigating
mechanisms underlying visual disease that may aid in the development of new preventative methods.

Public health relevance
The rapid increase in myopia worldwide, which is predicted to affect 50% of the world’s population by the year 2050, is thought to be driven by significantly less time spent in bright, outdoor spaces. Thus, there is a pressing need to understand how diverse signaling pathways regulate myopia development in different environments. This project will investigate how the retinal pathways that signal dark and bright features of visual scenes are affected in myopic eyes and their role in myopia progression, providing important insight into how visual environments could be optimized for effective intervention.